Hearing Loss by the Synergistic Effect of Chronic Inhalation of Exposure of Manganese Fumes with Occupational Noise Exposure

Abstract
Workers in industries such as mining, welding, smelting, and ceramic industry were chronically exposed to
Manganese (Mn) fumes. The percent risk of Mn toxicity by inhalation is high. This occupational exposure by
inhalation leads to Mn accumulation in the extrapyramidal system of the brain and manifests neurological
symptoms similar to Parkinsonism referred to as Manganism. Welders exposed to Mn fumes were evidenced
by hearing loss clinically. However, workers in these occupational settings were further exposed to occupational
noise as well and at the highest risk for occupational noise-induced hearing loss. Given the high socio-economic
impact of occupational noise exposure and Mn toxicity, it is vital to determine if Mn fume inhalation is ototoxic
and Mn fume inhalation potentiates occupational noise-induced hearing loss or occupational noise exposure
potentiates Mn fume-induced ototoxicity. Toxicokinetics and toxicodynamics of Mn toxicity are determined
oxidative nature of exposure in addition to dose, route, and duration. Recent evidence indicates that the
determination of the Mn species and Mn complexes with low molecular mass compounds (Mn-LMMs) in serum
could be a potential marker for biomonitoring of occupational Mn exposures. An earlier study indicated that Mn
exposure results in Mn accumulation in the cochlea and brain regions. Given the clinical evidence of hearing
loss and in vitro ototoxicity, we hypothesized that chronic Mn fume inhalation might be ototoxic and potentiate
occupational noise-induced hearing loss. Thus, in the proposed study, the central objective is to determine if
chronic inhalation of Mn fumes induces hearing loss and if it has a synergistic effect with concurrent occupational
noise exposure. This objective will be tested using three specific aims in the animal model of a chinchilla exposed
to Mn aerosols and occupational noise exposure. Chinchilla is used as a model as its audiogram and the size
of the tympanic membrane are similar to humans. Aim1 characterizes the Manganese fumes-induced hearing
loss and its potentiating effect by occupational noise exposure in chinchillas using various metrics of functional
auditory assays indicating the integrity of the auditory system. Aim2 investigates Mn metallomics by determining
the spatial distribution and localization of Mn-species and Mn-LMMs in the central auditory pathway (cochlear
nucleus, inferior colliculus, and auditory cortex) along with its quantification in serum and cochlea following
chronic Mn fume inhalation. Aim 3 characterizes the chronic Mn fume inhalation-induced cochlear histopathology
using cytocochleogram and synaptic cochleogram. The proposed study addresses the NORA sector of mining.
In addition to establishing Mn-induced ototoxicity and its potentiating effect, the study outcome provides insights
on Mn pathomechanism causing Manganism and as Research to Practice the study helps to determine exposure
standards for different oxidation states and improves risk assessment in these workers.

Public health relevance
Project Narrative Occupational noise-induced hearing loss is a major occupational disease resulting in tremendous socioeconomic and disease burden in industrial workers. In addition, these workers are exposed to chronic Manganese fumes by inhalation which results in a disease referred to as Manganism which will be addressed in the proposed study.